Improving Minority Health in Rheumatic Disease (IMHeaRD)

Project Summary – Administrative Core
The Administrative Core of the Core Center for Clinical Research (CCCR) for Improving Minority Health in
Rheumatic Diseases (IMHeaRD) at the Medical University of South Carolina provides leadership and
management for the center and a pilot projects program that is funded entirely with institutional commitments.
The mission of this CCCR is to advance knowledge with respect to the clinical care and health outcomes of Black
patients who have, or who are at risk of developing, systemic lupus erythematosus, scleroderma and other
debilitating rheumatic diseases. The overarching goals of the Administrative Core are to: (a) ensure the quality,
validity, accessibility and applicability of the tools, services, samples, data and other output of the CCCR cores,
(b) foster interactions among basic, translational and clinical scientists at MUSC and beyond to focus effectively
on prevention, diagnosis and treatment of rheumatic diseases, (c) facilitate appropriate dissemination of research
results and resources, and (d) establish/continue collaborations with other CCCRs/CORTS to share best
practices, methodology and unique skills. To achieve these goals, we will pursue the following specific aims: 1.
Provide leadership for the CCCR; 2. Coordinate and manage CCCR organizational, operational and financial
functions and evaluative activities; 3. Leverage institutional infrastructure resources; 4. Conduct a multi-year
Evaluation Plan; 5. Strengthen and expand robust communication, dissemination and outreach activities,
fostering mutually productive interactions among health professionals, scientists and local communities; and 6.
Provide a competitive Pilot Projects Program. This core will be directed by Jim Oates, MD, with assistance from
two Associate Directors, Gary Gilkeson, MD, and Diane Kamen, MD, an Executive Committee that includes core
leaders and Research Community representatives, an Internal Advisory Committee that includes institutional
stakeholders and patient advocates, and an External Advisory Committee that includes experts in the field with
experience leading other NIAMS centers. The Administrative Core staff provides administrative support for the
center, administering and monitoring the finances, coordinating meetings and action items, and interfacing with
NIAMS staff and institutional personnel. The Administrative Core also supports educational and dissemination
activities to enhance the visibility and impact of the center within MUSC and the local community and provide a
forum for communicating and exchanging research ideas. The Administrative Core nurtures a vibrant, interactive
program of clinical and translational research to advance our knowledge and resources for improving the
prevention, diagnosis, treatment and health outcomes for rheumatic diseases, notably systemic lupus
erythematosus and systemic sclerosis, which occur significantly more often and with greater severity in Black
patients than in other racial and ethnic groups in the United States.